Hepatic Nicotinamide N-Methyltransferase (NNMT) as a Pathogenetic Mechanism and Therapeutic Target for Alcoholic Liver Disease

Abstract
Despite much progress, alcoholic liver disease (ALD) remains a major health problem worldwide. The
disease process is characterized by early steatosis, steatohepatitis, with some individuals ultimately
progressing to fibrosis/cirrhosis and liver failure. Unfortunately, there is currently no accepted therapies
available to halt or reverse this process in humans. Nicotinamide N-methyltransferase (NNMT) catalyzes
SAM-dependent degradation of nicotinamide, a predominant precursor for cellular NAD+ biosynthesis via
a salvage pathway. SAM (s-adenosylmethionine) is the first product of methionine metabolism and a
universal methyl donor in cellular transmethylation reactions. The critical role of NNNT in regulating both
NAD+ and SAM homeostasis make it an emerging novel metabolic regulator. We are the first to report
that the liver ATF4 transactivation plays a mechanistic role in mediating NNMT upregulation in the setting
of chronic alcohol consumption and adenoviral shRNA knockdown of NNMT is protective against
alcoholic fatty liver development, suggesting that NNMT can be an ideal therapeutic choice for ALD
treatment. The preliminary data recently obtained from our laboratory uncovered that NNMT inhibition
was associated with improved mitochondrial unfolded protein response (UPRmt) and blunted hepatic
PPAR-gamma activation upon chronic alcohol exposure. In this proposal, we will further elucidate the
mechanistic implication of NNMT in the pathogenesis of ALD. Successful performance of the studies
proposed in this proposal will not only shed new light on the pathogenesis of this disease, but also pave
the way for novel therapeutic interventions for ALD. The three aims are included in this proposal to test
our hypothesis: AIM 1: To delineate mechanism(s) underlying NNMT-associated liver pathologies in ALD.
Both animal and cell culture studies will be conducted to elucidate mechanism by which NNMT inhibition
improves UPRmt elicitation in the liver and to determine the mechanism whereby NNMT upregulation
contributes alcohol-induced liver PPAR-gamma activation. AIM 2: To elucidate mechanism(s) by which
chronic alcohol consumption leads to hepatic ATF4 activation and NNMT upregulation. Both hepatocyte-
specific Gcn2 knockout mice and hepatocyte-specific arginase-1 overexpressing mice will be fed with
isocaloric control or alcohol-diet for 5 weeks. Targeted metabolomics will be conducted to using primary
hepatocytes to quantify the effects of alcohol on hepatic arginine metabolism. AIM 3: To determine both
preventive (the pathogenic role) and therapeutic potential of NNMT-targeting approach for ALD. Animals
with liver-specific NNMT knockout will be exposed to either isocaloric control or alcohol-diet. Both
preventive and therapeutic efficacy of NNMT inhibition for ALD will be evaluated.

Public health relevance
Project Narrative Liver damage induced by chronic alcohol drinking (alcoholic liver disease, ALD) remains an important health problem in the United States and ranks among the major causes of morbidity and mortality in the world, and affects millions of patients worldwide each year, with no accepted therapy available to halt or reverse this process in humans. The recent preliminary studies in our laboratory demonstrated that chronic alcohol exposure is associated with increased expression of nicotinamide N-methyltransferase (NNMT) in the liver. Our further investigations suggest that NNMT inhibition confers protection against alcohol-induced fatty liver development, suggesting that NNMT plays a pathological role in the development of ALD and represent an ideal therapeutic target for the clinical intervention. In this proposal, we will utilize state of the art approaches to test our hypotheses using both cell culture and animal models.